Planarian behavioral screening of ToxCast Phase I chemicals to determine context of use

Objectives. The developing brain is highly vulnerable to chemical toxicants, but <2% of environmental chemicals
have been tested for developmental neurotoxicity (DNT). This data deficit results from the extreme cost and time
requirement of mammalian testing. There is an urgent need to develop high-throughput screening (HTS) models
to replace, refine, and/or reduce (“3Rs”) vertebrate testing. The development of HTS models is especially
challenging for neurotoxicity (NT) and DNT where the functional relevancy of adverse outcomes needs to be
assessed on the whole organism level. The overarching goal of this research is to develop a cost-effective
invertebrate organismal HTS test method to identify NT and DNT to complement existing in vitro tests. The
specific objective is to determine the applicability domain and utility of HTS using the asexual freshwater
planarian Dugesia japonica as a first-tier behavioral screening platform for NT/DNT. This will be achieved by
screening the ToxCast Phase I library, consisting of 293 unique, data-rich compounds, and comparing the results
to existing data from mammalian, in vitro, and alternative organismal models. Planarians are invertebrates of
intermediate neural and anatomical complexity compared to nematodes and zebrafish and have tractable,
evolutionarily conserved neuronal circuits. Planarians uniquely allow for direct comparison of xenobiotic effects
on the adult and developing nervous systems. We hypothesize that planarian behavioral HTS adds
complementary value to existing testing methods because of its unique strengths (full metabolism at all
developmental stages, screening into adulthood, parallel screening of adult and developing organisms).
Experimental approach. In Aim 1, we will use the ToxCast Phase I library to profile behavioral phenotypes in
intact and regenerating planarians to identify the neurotoxic effects of different chemicals’ domains. We will first
test each chemical at 100 µM. Chemicals that elicit effects at this concentration will then be tested across 7
concentrations. Effects will be quantified as benchmark concentrations for 37 readouts over two time points.
Development-specific effects will be extracted by comparison of adverse outcomes in intact vs. regenerating
planarians. In Aim 2, we will compare concordance with mammalian guideline data and publicly accessible
ToxCast Phase I data from in vitro, nematode, and developing zebrafish assays. We will also determine planarian
HTS performance for specific chemical domains to assess context of use. These comparisons will inform on
whether planarian HTS recapitulates animal NT/DNT, adds complementary information to NT/DNT in vitro tests,
and how it performs compared to more established non-animal organismal models.
Expected results: This project will evaluate how the planarian system captures the chemical subspace of this
chemically diverse library and how our results compare to data in existing models. This will determine the context
of use of this promising first-tier NT/DNT screening system and bolster the development of a comprehensive
non-animal DNT testing battery, to meet the urgent need to fill the DNT data gap and reduce animal testing.

Public health relevance
Project Narrative: There is an imminent need to develop high-throughput non-animal models that can replace, refine, and/or reduce (“3Rs”) animal toxicity testing to better understand the health impacts of the thousands of chemicals that we encounter in our environment. This is especially true for understanding how chemicals affect the developing nervous system, which has been undertested due to the extreme cost and time requirement of traditional animal testing. The goal of this research is to use a large, well characterized library of chemicals to evaluate the utility and context of use of high-throughput behavioral screening using freshwater planarians as an invertebrate method for neurotoxicity and developmental neurotoxicity screening.